Parkinson's Disease Neuroprotection Clinical Trial

DESCRIPTION (provided by applicant): The Parkinson's disease neuroprotection clinical trial is currently trying to determine if creatine is neuroprotective in the treatment of Parkinson's disease. As part of this multicenter trial, we have enrolled 21 patients and are currently followin 20 of these patients. We plan to continue to retain and follow these patients in the trial for the next 3 years or to completion (see specific aims section).

Public health relevance
PUBLIC HEALTH RELEVANCE: A neuroprotective treatment would ease the burden of Parkinson's disease by increasing the functional life of patients with this condition.